Neuroscience Training at Wake Forest

Project Summary
Neuroscience PhD training has been a component of graduate student training at Wake Forest University for
approximately 28 years. The field of Neuroscience is at the cutting edge of scientific developments and the
Wake Forest Neuroscience Program believes its long-term returns from student training will have positive
consequences for our community and nation. Neurological disorders associated with trauma, an aging
population, drug addiction, neurodevelopmental and psychiatric disorders represent urgent local and national
needs. Immediate action is required. As scientists and educators, we have a responsibility to train individuals
capable of pioneering research into both normal development and function of the nervous system and into the
causes and mechanisms underlying neurological disease.
The goal of our Neuroscience training program is to provide students with
a) A fundamental understanding of all levels of nervous system organization, from genetics, molecular, and
cellular to systems and behavioral,
b) The skill set that includes extensive training in experimental design and interpretation, statistical and
quantitative methodology and hands on experience in state of the art laboratories to carry out meaningful
and significant research in all areas of modern neuroscience, and
c) An appreciation of the importance of how basic neuroscience research is key to finding treatments for
neurobehavioral pathologies.
This is achieved because the first, two years the program focus on providing students with the broad-based,
interdisciplinary training that includes a balance of coursework with essential hands-on lab research training.
With this foundation in place, students move forward using the next few years to investigate and develop a
thesis project in a specific neuroscience subdiscipline such as memory and cognition, addiction and motivated
behaviors, sensory integration, or nervous system changes following injury or in disease. Our program’s
success occurs because in addition to an established advisory structure, students are exposed to a research
setting in which collaborations and interactions among investigators using different techniques and approaches
is commonplace. Additionally, while preparation for a research career in the Neurosciences remains a central
focus of our program, we consider it essential for students to have access to teaching, outreach and other
professional experiences to be fully cognizant of the increasing opportunities for both non-academic and non-
research careers that utilize their scientific and scholarly training.

Public health relevance
Project Narrative The primary purpose of the program is to train the next generation of neuroscientists capable of developing productive research programs and the skills to adapt to changing technologies and new understandings. We are committed to our students’ career development and provide several opportunities for our students to provide them with a strong arsenal of rigorous experimental and analytical training and experience to make them competitive for the increasing opportunities for both non-academic and non-research careers that utilize their scientific and scholarly training.